Multidimensional analysis of the regulatory T cell response in children with severe viral pneumonia

Abstract
Respiratory viruses are ubiquitous pathogens that cause a spectrum of clinical diseases ranging from
asymptomatic carriage to severe pneumonia. Healthy children are much more likely to develop severe
viral pneumonia than healthy adults and lung injury during childhood is associated with long-term
impairments in respiratory health. There is a paucity of information regarding why children are highly
susceptible to viral pneumonia and how they recover from severe disease. Children with severe viral
pneumonia present to the pediatric intensive care unit with an established infection and lung injury.
Currently, therapies for viral-induced lung injury are supportive and do not directly modify the pathology or
accelerate recovery. Thus, there is a need to understand the age-specific mechanisms that promote recovery
from severe viral pneumonia in children to aid in developing novel therapeutic strategies. Infection of mice
with murine-adapted strains of influenza A virus (IAV) mimics many of the clinical features of severe viral
pneumonia. Our group developed a mouse model of IAV infection that recapitulates clinical disease in children
less than 5 years of age. We previously reported that juvenile mice exhibit a persistent, excessive
inflammatory response to IAV despite adequate viral clearance. The resulting lung injury suggests juveniles
fail to resolve inflammation and fail to repair the alveolar epithelium during severe disease. Regulatory T (Treg)
cells mediate inflammation resolution and tissue repair. Adult murine models define an essential role for Treg
cells in the recovery from severe viral pneumonia, however, studies in age-appropriate murine models are
lacking. This proposal hypothesizes that during severe viral pneumonia in children, the reparative function of
Treg cells is impaired, and Treg cells fail to mitigate excessive proinflammatory responses and promote tissue
repair. The specific aims are 1) Determine whether juvenile regulatory T cells have impaired reparative
functions during severe viral pneumonia, 2) Determine whether the age-specific lung microenvironment during
severe influenza pneumonia affects regulatory T cell pro-recovery functions, and 3) Determine if alveolar
regulatory T cell transcriptional signatures are associated with outcomes in pediatric patients with severe viral
pneumonia.The project was explicitly designed to facilitate the career development of the primary
investigator (PI). It will provide experiential learning augmented with structured training opportunities to
advance the PI to independent investigator status. Specific training domains include advanced methods of
assessing alveolar injury and repair, flow cytometric analysis of immune cell phenotypes, assays to
assess T cell function, systems biology approaches to identifying novel genomic determinates of T cell
function, and design of translational studies using patients’ clinical and molecular data. This proposal will lay
the foundation for an iterative translational approach the PI can continue to use throughout his career to
achieve his long-term goal of identifying therapeutic targets to hasten recovery and improve long-term
respiratory health of children with severe viral pneumonia.

Public health relevance
Project Narrative Children are disproportionately affected by respiratory viruses and at risk of developing severe viral infections requiring admission to the pediatric intensive care unit. Once a child develops a severe disease, treatment options are currently limited to supportive measures that do not treat the underlying pathology. This proposal will provide insight into how the pediatric immune system promotes recovery from severe viral respiratory infections to inform the design of new treatments aimed at accelerating recovery and reducing the risk of complications from severe viral respiratory infections.